EPIDEMIOLOGY OF DIABETES INTERVENTION AND COMPLICATIONS (EDIC)

The Epidemiology of Diabetes Intervention and Complications (EDIC) is primarily an epidemiologic investigation, especially for the study of macrovascular disease in insulin dependent diabetes mellitus (IDDM), and it also takes advantage of intention to treat analyses based on previous involvement of the study population in the Diabetes Control and Complications Trial (DCCT).